Selective, epineural stimulation of peripheral nerves with interferential electrical fields

Selective, epineural stimulation of peripheral nerves with interferential electrical
fields
Project Summary/Abstract
Most existing PNS interfaces do not adequately target nerve fibers mediating specific physiological functions
and innervating specific organs or muscles. Nonselective activation of nerve fibers may lead to reduced PNS
efficacy and unwanted side effects. PNS that selectively activates specific fiber populations in a nerve would
be desirable for mechanistic and translational studies but is not currently feasible. The anatomical organization
of autonomic (e.g., the vagus nerve, VN) and somatic nerves (e.g., the femoral nerve, FN) is amenable to
fascicular neurostimulation using multi-contact cuff electrodes (MCEs), which have a favorable safety profile.
We hypothesize that multi-source, intermittent interferential current stimulation (i2CS) delivered through an
MCE that accommodates the fascicular anatomy of the nerve is a viable strategy for PNS, superior to current
state-of-the-art methods. Aim 1 will test the hypothesis that interference arising from superposition of currents
of slightly different frequencies delivered through separate electrode contacts, focuses electric fields and
selectively activates specific fascicles inside the trunk of multi-fascicular nerves. It will also establish that i2CS
is superior to other methods of PNS and characterize how stimulation parameters affect efficacy and
selectivity. Aim 2 will develop and validate a design methodology, based on computer simulations of nerve
interfaces, for determining the preferred contact configuration of an MCE for effective iCS delivered to a given
autonomic or somatic nerve. It will also develop and validate a methodology for optimizing i2CS stimulation
paradigm on an individual subject basis. In the long run, PNS targeting specific fiber populations could improve
efficacy and safety of existing therapies and open up new therapeutic indications.

Public health relevance
Project Narrative Selective peripheral nerve stimulation (PNS) may be associated with improved safety and efficacy compared to current, largely non-selective, approaches. Fibers in autonomic and somatic peripheral nerves are organized in fascicles, lending themselves to selective PNS. This project will test whether PNS based on intermittent interferential current stimulation delivered through a multi-contact cuff electrode device is a viable strategy for selective PNS, superior to state-of-the-art methods.